JAK/STAT signaling in the pathogenesis of DNMT3A mutant T-ALL

ABSTRACT
Like other cancers, T-cell acute lymphoblastic leukemia (T-ALL) arises from the accumulation of genetic
abnormalities that impair function of immature T-cell progenitors. DNMT3A, which encodes a de novo DNA
methyltransferase enzyme that catalyzes the establishment of new DNA methylation marks on the genome, is
recurrently mutated in 10-18% of adult T-ALL cases and confers a poor clinical prognosis. We recently
showed using genetic mouse models that Dnmt3a acts as a T-cell tumor suppressor. Introduction of an
activating Notch1 mutation into a Dnmt3a loss-of-function genetic background (a common genetic combination
in patients) generated a lethal T-ALL with half the latency period compared to T-ALL with wild-type Dnmt3a.
Dnmt3a-mutant T-ALL blasts are resistant to cell death, both in vivo and under different stress conditions. This
suggests a major biological function of DNMT3A mutations in T-ALL cells is to make them “harder to kill”, and
the inferior clinical outcomes of these patients may be due to resistance to standard chemotherapy regimens.
We have now uncovered a potential mechanism to explain this which is conserved in both Dnmt3a-mutant
mouse T-ALL models and primary human DNMT3A-mutant T-ALL patient samples. DNMT3A-mutant T-ALL
cells are hypersensitive to cytokines such as IL-6 and IL-7, which results in elevated JAK/STAT signaling
triggering a pro-survival gene expression program. Specifically, we hypothesize that DNMT3A-mutant T-
ALL cells are resistant to apoptosis due to pSTAT5-dependent upregulation of BCL-xL. The goals of
this proposal are to understand the molecular mechanisms driving these phenotypes and exploit them for novel
therapeutic interventions. We will test this hypothesis with the following Specific Aims;
 Determine the role of STAT5 and BCL-xL in the pathogenesis of DNMT3A-mutant T-ALL
 Define the role of JAK/STAT signaling in chemoresistance of DNMT3A-mutant T-ALL.
 Identify molecular mechanisms underpinning the functional phenotypes of Dnmt3a-mutant T-ALL.
We will leverage preliminary findings to interrogate this hypothesis using a complementary combination of
genetic mouse models, human patient-derived xenografts, and CRSIPR/Cas9 genome engineering. In Aim 1,
we will evaluate the importance of STAT5 and BCL-xL for the development and maintenance of DNMT3A-
mutant T-ALL (both mouse and human) using state-of-the-art genetic tools. In Aim 2, we will use genomic
assays to understand how DNMT3A-mutant T-ALL cells are resistant to chemotherapy, and if JAK/STAT
inhibition can resensitize these cells to chemotherapeutic agents in vivo. In Aim 3, we will determine the
importance of DNA methylation at enhancers in the generation of pathogenic gene expression programs for
this T-ALL subtype, and evaluate the role of SHP-1 in conferring cytokine hypersentivity to DNMT3A-mutant T-
ALL cells. We will use the results of this project to inform design of rationally-targeted precision medicine
strategies for the treatment of T-ALL patients based on their underlying genetics.

Public health relevance
PROJECT NARRATIVE In adults, T-cell acute lymphoblastic leukemia (T-ALL) is an aggressive hematopoietic cancer with a poor overall survival, high relapse rate, and significant treatment-related side effects due to intense chemotherapy regimens. Using mouse genetic models and primary T-ALL patient samples, this project will study the importance of JAK/STAT signaling in the pathology of T-ALL driven by loss-of-function DNMT3A mutations. The main goal of these research efforts is the development of precision medicine approaches for DNMT3A- mutant adult T-ALL patients, a group with poor clinical outcomes and no established standard-of-care for relapsed patients.